Regulation of LDAM by autopahgy in the aging brain

During brain aging and in neurodegenerative diseases such as Alzheimer’s disease (AD), microglia lose their
homeostatic properties, gradually becoming activated and pro-inflammatory. While the transcriptional changes
occurring in aging- and neurodegenerative disease-associated microglial populations have been characterized,
many questions regarding their generation remain.
Because of prevalent branched cells and presence of cholesterol-rich myelin, CNS has overall higher levels
of lipids than most other tissues except the adipose. As the resident phagocytic cells of the brain, microglia are
responsible for clearing dead cells and cellular debris, including lipids. Recent data indicate that phagocytosis of
certain lipids, in particular cholesterol, can cause lysosomal disruption. This has been documented in tissues
high in cholesterol such as atherosclerotic plaques, where accumulation of lipid droplets in foam macrophages
is associated with lysosomal dysfunction. Lipid droplet associated microglia (LDAM) are also observed in the
aged mouse, aged human and AD patient brains and have properties and transcriptional profiles resembling
foam macrophages, however the mechanisms contributing to their formation are not fully understood.
Lysosomal dysfunction causes inhibition of autophagy, a lysosome-dependent catabolic pathway, which has
been linked to brain aging, AD, and other neurodegenerative diseases. Recent data demonstrate that in addition
to its well-established role in protein homeostasis, autophagy participates in regulation of cellular lipid catabolism
and inflammation. We hypothesize that myelin lipid phagocytosis by microglia leads to lysosomal and autophagy
inhibition, which in turn exacerbates defects in lipid metabolism and accelerates formation of LDAM. In AIM 1 we
will determine the mechanisms how lipid phagocytosis leads to inhibition of microglial autophagy in the aging
brain. In AIM 2 we will identify the autophagic mechanisms contributing to accumulation of lipid droplets and
formation of LDAM and other pathological microglial populations. In AIM 3 we will determine whether increasing
autophagy can attenuate LDAM formation and microglial inflammation associated with brain aging. We expect
our data will identify the interaction between microglial lipid metabolism and autophagy pathways as important
contributor to generation of age- and neurodegeneration-associated microglial population and demonstrate that
increasing autophagy can attenuate this process and improve function of aged microglia.

Public health relevance
PROJECT NARRATIVE Epidemiological and experimental evidence links changes in both lipid metabolism and the degradative process of autophagy to brain aging and development of Alzheimer’s disease (AD). However, it remains poorly understood how these processes may interact to accelerate brain aging and neurodegeneration. We propose to use modern experimental and analytical tools to dissect the connection between microglial lipids and autophagy and their influence on age-related brain inflammation and development of neurodegeneration.